Defining the Neuro-Immune and Placental Profile of a Dual-Hit Toll-like Receptor 7 and Stressor Mouse Model

Project Summary
Maternal infection during pregnancy increases the risk of neuropsychiatric disorders. Although maternal immune
activation during pregnancy is a strong risk factor for neurodevelopmental disorders, most cases of maternal
infections do not result in neuropsychiatric disorders. However, maternal immune activations appear to act as
‘priming events’, sensitizing the immune system and increasing susceptibility to subsequent perturbations. Early-
life adversity, such as maltreatment or neglect, increase the risk for stress-related disorders. Epidemiological
studies have found enhanced susceptibility to a second ‘hit’ of adversity stress. Indeed, two-hit models of
maternal immune activation and stress induce robust alterations in offspring behavior.
Rodent models of maternal immune activation typically induce immune activation through infectious agents such
as bacteria or double-stranded RNA. However, some of the prenatal infectious agents that are most strongly
linked to the risk for neurodevelopmental disorders are single-stranded viruses like rubella and influenza. The
recognition of single-stranded RNA by toll-like receptor 7 (TLR7) initiates a robust immune response. Although
the use of single-stranded mimetics that stimulate TLR7 are relatively underutilized in rodent maternal immune
activation models, recent data suggest that maternal TLR7 activation during pregnancy induces a robust
maternal immune response and impacts offspring neurodevelopment and behavior.
Here, we will use a model of maternal TLR7 stimulation by the single-stranded mimetic imiquimod in combination
with early postnatal resource deprivation stress through caging in limited bedding and nesting environments.
The central hypothesis of this R21 proposal is that a novel two-hit model of maternal immune activation using
TLR7 activation by imiquimod during pregnancy in combination with early postnatal resource deprivation stress
through LBN results in sex-specific neurodevelopmental susceptibilities. In Aim 1, we will determine whether
prenatal TLR7 stimulation induces maternal, placental, and offspring brain inflammatory responses in a sex-
biased manner. We will assess whether maternal immune activation induces placental macrophage and fetal
brain microglial priming. In Aim 2, we will determine whether microglial morphological alterations and pruning of
excitatory neurons in the anterior cingulate cortex, nucleus accumbens, paraventricular nucleus of the
hypothalamus, and ventral tegmental areas is induced by prenatal TLR7 stimulation in combination with early
postnatal resource deprivation stress by LBN. Determining whether this two-hit model of maternal TLR7
stimulation in combination with early-life resource deprivation stress results in inflammatory alterations within
placental macrophages and fetal brain microglia, along with altering microglial phagocytosis of neuronal circuits.

Public health relevance
Project Narrative Maternal infection during pregnancy increases the risk of neuropsychiatric disease/disorders in offspring; however, maternal immune activation does not induce neurodevelopmental disorder vulnerability in the majority of offspring. Here, we test whether maternal immune activation acts as a ‘priming event’, increasing susceptibility to subsequent risk factors such as early-life stress, exposure to which has been shown to increase susceptibility to neuropsychiatric disorders. In this R21 proposal, we will test the hypothesis that a two-hit model of maternal immune activation using toll-like receptor 7 activation during pregnancy in combination with early-life postnatal resource deprivation stress results in sex-specific neurodevelopmental vulnerabilities.